Center for Population Health and Aging

Project Summary (Overall)
The Duke Center for Population Health and Aging (CPHA) will continue to support an
interdisciplinary environment to develop faculty in aging research and to foster important
scientific breakthroughs, particularly in the overlapping areas of biodemography (i.e. biological
and biomedical demography of aging), life course studies of health and well-being across the
lifespan, and intergenerational studies including the transmission of health and longevity. These
activities will be supported by an infrastructure consisting of four integrated cores: (i) a strong
Administrative and Research Support Core (Core A) that provides central cohesive clerical,
technical, event planning and research support services including pre-award and post-award
grants and project management; (ii) programming in a Development Core (Core B) that
sponsors peer-reviewed pilot research initiatives and interactions with invited experts from
around the world; (iii) innovative inter-institutional networks of collaboration in research and
training both in the region and beyond focused on comparative animal models of aging in an
External Networks Core (Core C); and (iv) the rapid design and testing of methods aimed at
accelerating transfer of research to practice to create cost efficiencies in Core D.

Public health relevance
Project Narrative The Duke Center for Population Health and Aging (CPHA) supports rigorous, innovative research in biodemography, life course studies and intergenerational studies to understand the relationship between social and biological factors in healthy aging and longevity, to support and enlarge the community of demographic scientists working in population health, and to accelerate the transfer of research to practice.